Center for Immersive Learning and Digital Innovation: A Patient Safety Learning Lab advancing patient safety through design, systems engineering, and health services research

Project Summary
COVID-19 has seriously strained US healthcare work systems and exposed the critical need for a redesign of
current systems to improve quality of care and promote patient safety, particularly as to inpatient healthcare-
associated infections. Crucial to the redesign of those systems is a better understanding of human and system
factors in the evaluation of existing care processes, and the incorporation of immersive learning technologies
and digital innovation to train healthcare workers. In this project, Johns Hopkins Center for Immersive Learning
and Digital Innovations (CILDI) will utilize the systems engineering initiative for patient safety model to advance
the science of safety in preventing and controlling central line associated bloodstream infections (CLABSI). Our
research will consider and balance human and system factors, and utilize the AHRQ systems engineering
methodology to identify, design, develop, implement, and evaluate solutions to CLABSI. We will pursue the
following aims: 1) foster a new generation of interprofessional clinicians actively engaged in providing safe
patient care using virtual simulation and virtual reality to decrease the rate of CLABSI, 2) establish the Johns
Hopkins CILDI as an interdisciplinary and patient/family informed, sustainable infrastructure to advance the
science of patient safety in preventing and controlling CLABSI using augmented reality approaches, and 3)
leverage unique patient safety learning laboratory environment strengths to enhance translation of systems
engineering-based robotic interventions for optimal management of CLABSI. The Johns Hopkins CILDI will
include immersive learning, and engage a digital innovation advisory board, our project team, a systems
engineering and human factor advisory core and translational advisory core. The center science has high
potential to improve the quality of care processes and patient safety, and decrease CLABSI rates.

Public health relevance
Project Narrative The development of feasible, effective and scalable interventions to improve the safety of patients at risk for or with central line-related bloodstream infections, is urgently needed. The proposed Johns Hopkins Center for Immersive Learning and Digital Innovation (CILDI) will advance the science of patient safety through a sustainable infrastructure that will test innovative interprofessional interventions co-designed with individuals and families experiencing these conditions. CILDI will utilize a framework comprising a systems engineering initiative for patient safety model and the AHRQ systems engineering project life cycle, to measure patient safety and process efficiency in order to increase the relevance, uptake and sustainability of the interventions.